Microglial regulation of neuronal activity in TDP-43 neurodegeneration

PROJECT SUMMARY
Microglia, as the resident immune cells of the central nervous system, are key players in aging and
neurodegenerative diseases, such as Alzheimer’s disease (AD) and AD-related dementias (ADRD). However,
how microglia sense and regulate neurodegeneration remains largely unknown. TDP-43 is a DNA-binding
protein that is a main component of the protein aggregates found in amyotrophic lateral sclerosis (ALS),
frontotemporal lobar dementia (FTLD), and AD. We used inducible mouse model of TDP-43 translocation
(rNLS8) that can mimic characteristic features of TDP-43 related neurodegeneration. Utilizing in vivo two-
photon imaging, we have demonstrated that rNLS8 mice show neuronal hyperactivity in the cortex during
disease progression, which is associated with unique rod-shaped microglia aligning along neuronal dendrites
in the layer 4 cortex. Based on these exciting observations, we hypothesize that microglia have
neuroprotective roles by regulating cortical microcircuit and attenuating neuronal hyperactivity in
response to TDP-43 related neurodegeneration. We will test this hypothesis with the following three Aims:
Aim 1: Determine the functional heterogeneity of microglial activation in TDP-43 neurodegeneration.
We will use chronic, in vivo two-photon imaging to determine the spatiotemporal activation of microglia,
including process dynamics, landscape changes, and proliferation. In addition, we will examine microglial Ca2+
activity using a newly developed microglial GCaMP7s mouse line and TREM2 dependence. The results from
this aim will uncover microglial heterogeneity in different phases of TDP-43 related neurodegeneration.
Aim 2: Investigate how microglia regulate cortical microcircuits in TDP-43 neurodegeneration. We will
study microglia-neuron interactions in different cortical layers during disease progression and recovery in
rNLS8 mice using simultaneous two-photon and electron microscopy. We will also determine how microglial
TREM2 regulates neuronal circuits, particularly during the early phases of disease progress, in TDP-43 related
neurodegeneration.
Aim 3: Manipulate microglia as a potential therapeutic target in TDP-43 neurodegeneration. We will
precisely control microglial function using chemogenetics in the different phases of disease and delineate
microglial contributions. In addition, we will target TREM2 for treatment of TDP-43 related neurodegeneration.
Our group is perfectly poised to exploit novel methods of imaging microglia-neuron interactions and study their
precise function in aging and TDP-43 related neurodegeneration like ALS, FTLD and AD. These innovative
approaches will provide transformative insights into microglial mechanisms of regulating TDP-43 related
neurodegeneration and spawn putative therapeutic targets that will ultimately help patients with ALS, FTLD,
AD, and ADRD.

Public health relevance
PROJECT NARRATIVE The current proposal aims to study microglial activation, microglia-neuron interaction and neuroprotective function of microglia in TDP-43 neurodegeneration, such as FTLD and ALS. This study will improve our understanding of cellular and circuit mechanisms underlying microglial function in TDP- 43 neurodegeneration. The mechanisms may also serve as a common model to address microglial regulation of neuronal circuit in aging and, AD and ADRD.